ISIC-REPO; ISIC Skin Imaging Repository Enhancements for Promoting Interoperability and Utilization

SUMMARY
The International Skin Imaging Collaboration (ISIC)'s overarching goal is to leverage technology to reduce skin
cancer mortality and morbidity. The ISIC Archive, created and led by Memorial Sloan Kettering Cancer Center
since 2016, is the leading publicly available skin imaging repository. With >240 000 images, >6000 registered
users, and 17-21 million image downloads per month, the ISIC Archive has made major contributions to
dermatology teaching and the development of artificial intelligence (AI) for skin cancer diagnosis. ISIC has also
been central to the development and adoption of standards for skin imaging to promote quality and
interoperability. ISIC has hosted 5 machine learning Grand Challenges and hosts continuous Live Challenges
using ISIC Archive images. ISIC Challenges have attracted 6818 participants and 25 326 submissions. ISIC
has directly published 21 scientific papers, while another 260 peer reviewed papers and 3060 technical reports
have relied on ISIC data. Here, we propose to develop the ISIC Archive into an even greater resource for
research through major enhancements that focus on making the ISIC Archive fully compliant with FAIR
principles (findability, accessibility, interoperability, and reusability), while expanding the Archive with additional
support for broadly used data formats (eg, Digital Communications Standards in Medicine [DICOM]) and skin
imaging modalities (clinical imaging, total body photography [TBP]). We propose to leverage ISIC's leadership
in the DICOM community to improve software support for established skin imaging standards, while publishing
new standards for TBP, and to improve quality and interoperability for these imaging modalities. We have
organized key milestones for this proposal under 4 specific aims: (1) to bring the ISIC Archive into rigorous
compliance with FAIR principles; (2) to overcome the challenges of ingesting and sharing clinical images and
representations of TBP while maintaining patient privacy and addressing sensitivity; (3) to strengthen the
interoperability of ISIC data through the use of DICOM; and (4) to implement approaches to facilitate scaling,
disseminating, and sustaining the ISIC data repository. The resulting ISIC Archive will be a more scientifically
robust, impactful, and sustainable resource. ISIC will continue to promote use of the Archive and engage the
dermatology and computer science communities through Challenges, workshops, and publications. By
promoting and supporting research to effectively leverage skin imaging and AI to diagnose skin cancer earlier
and more accurately, we will save lives and reduce the morbidity associated with unnecessary biopsies and
the treatment of advanced disease.

Public health relevance
NARRATIVE The International Skin Imaging Collaboration (ISIC) Archive is the leading publicly available skin imaging repository and has made major contributions to the dermatology and computer science communities' efforts toward the development of visual aids and artificial intelligence tools for skin cancer diagnosis. In this project, we will make the ISIC Archive fully compliant with the FAIR principles (findability, accessibility, interoperability, and reusability), expand the Archive to include clinical images and total body photography, and advance the development and application of skin imaging standards to improve quality and interoperability. Through these major enhancements, we will make the ISIC Archive a considerably more useful, impactful, and sustainable resource for research to improve the early and accurate diagnosis of skin cancer.